Mapping and modeling inhibitory interneurons in Alzheimer's disease and related dementias: novel strategies to reverse neural network dysfunction

ABSTRACT
Alzheimer’s disease (AD) and AD-related dementias (ADRD) are prevalent and costly, with no
disease-modifying therapies. Emerging data demonstrate that disruptions within inhibitory
interneurons contribute significantly to AD/ADRD pathophysiology. Interneurons normally
regulate excitatory firing of neuronal networks, enabling the tuning and adaptability of circuits
which subserve functions such as memory and cognition. Altered interneuron inhibition is seen
in brains of human AD/ADRD subjects, which leads to hyperexcitability, hypersynchrony, and
epileptiform activity that impairs memory and cognition. Synaptic overactivity also increases
amyloid beta (Aβ) levels, while enhancing interneuron inhibitory activity promotes Aβ clearance.
Yet, the upstream causes of interneuron dysfunction in AD/ADRD are unclear. There is a critical
need to define mechanisms of interneuron pathology and the resultant hyperexcitability in
AD/ADRD to develop effective therapies. This proposal will catalog mediators of interneuron
dysfunction, and develop strategies to reverse this pathology. Our central hypothesis is that
abnormal mitochondrial function is a major and early contributor to interneuron dysfunction, and
that transplantation of iPSC-derived interneuron precursors will restore cognitive and memory
circuits. Our rationale is that, by defining faulty interneuron biology and connections, concrete
therapeutic targets will be made feasible for AD/ADRD. We have three Aims. Aim 1 will identify
disrupted interneuron gene expression by studying interneurons within hippocampal and cortical
subregions of human post-mortem AD brain. Using a spatial transcriptomic whole transcriptome
approach, we will map aberrant interneuron genes and identify mechanistic targets for reversing
hyperexcitability and restoring cognitive function. Aim 2 will define inhibitory dysfunction in vitro
by characterizing AD-derived induced interneurons using metabolic phenotyping,
immunocytochemical staining, and Aβ toxicity assays. AD-derived interneurons will then be
modified to express genes aimed at reversing abnormalities seen in prior studies with the goal
of restoring interneuron regulatory physiology. This aim will determine whether corrected
interneurons represent a viable patient-specific therapeutic strategy. Aim 3 will transplant
healthy induced interneurons into hippocampal structures of an AD mouse model, assessing
graft survival and hippocampal-based memory performance. Here, we will determine the impact
of interneuron augmentation on behavior and neurodegeneration in vivo, providing a rationale
for future cell-based therapies. Overall, understanding interneuron pathophysiology and its
contribution to neural circuit dysregulation in AD/ADRD will help uncover innovative treatments
for AD/ADRD and similar illnesses involving dysregulated neural networks.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) and AD-related dementias (AD/ADRD) are a major public health concern, costing over $321 Billion and affecting more than 6.5 million individuals in the United States alone, and these numbers will continue to grow with our aging population. The exact causes of AD/ADRD are unknown, although an important component involves dysfunction of regulatory brain cells, called inhibitory interneurons, and results in over-excitation and abnormal activity in brain circuits that serve memory and cognition. In our planned research, we aim to define the causes for inhibitory interneuron dysfunction and find ways to reverse this problem, advancing the mission of the NIH to decrease illness, reduce disability, and prolong life for AD/ADRD patients.